Defining the Role of Tumor-Neutral Crosstalk in head and Neck Cancer Progression and Treatment Resistance

PROJECT SUMMARY
Solid tumors can shape their microenvironments to maximize their growth and metastatic potential. The
formation of new nerve fibers within and around tumors can alter tumor behavior, and higher densities of nerve
fibers in the tumor microenvironment are associated with poor clinical outcomes in patients with oral, prostate,
breast, gastric, pancreatic and other types of cancer. Preclinical and pathological studies have described
neoneurogenesis, the process by which cancer cells induce the growth of nerves into tumors, as analogous to
neoangiogenesis, in which cancer cells release factors that elicit the growth of blood vessels into the tumor.
However, the exact mechanisms that drive nerves to infiltrate tumors and support their growth and progression
is unknown. Preliminary research shows that cancer cells ‘communicate’ with neurons through shuttling of p53-
dependent RNA species that further induce tumor innervation. The hypothesis of this study is that axonal
sprouting and autonomic reprogramming of existing nerves occur as a result of orchestrated miRNA shuttling
from cancer cells to neurons and via activation of the transcriptional programs that establish neuronal identity
and that infiltration of tumors by autonomic neonerves enables tumor progression. The neonerve’s phenotype
includes transformation into a sprouting cell able to infiltrate and interact with other cell types, the release of
adrenergic neuroactive molecules, and the development of neurogenic inflammation. Each of these acquired
capabilities may promote tumor progression and resistance to therapy. The proposed research is innovative
because it will capitalize on new concepts in cancer biology and advanced model systems to yield insights into
the mechanisms of tumor progression and identify new targets for cancer therapy. This cross-disciplinary
proposal will combine expertise from oncology, neurodevelopment, cell biology, neurobiology, cancer genetics,
pathology, and biostatistics to pursue three specific aims: (1) Delineate the signaling events that occur between
cancer cells and neurons during tumorigenesis, using pharmacologic and genetic approaches to understand
how cancer cells cause normally quiescent neurons to reprogram and continually sprout to sustain neoplastic
growth. (2) Elucidate the drivers of tumor-associated neuronal reprogramming. By using human-derived sensory
neurons, we will determine how the normal nerve response to signals from cancer cells supports cancer
progression. (3) Characterize sensory nerve reprogramming and its role in oral cancer progression. Using a
genetically engineered syngeneic mouse model, we will elucidate the neural-tumor interactions that lead to
neurogenic inflammation and promote oral cancer progression. Our long-term goal is to elucidate the reciprocal
nerve-cancer signals that drive cancer progression to identify novel targets for therapy. Once the signals that
induce tumor innervation are known, therapeutic approaches to target this critical component of tumor biology
can be developed to improve survival, treatment responses, and patients’ quality of life.

Public health relevance
PROJECT NARRATIVE The solid tumor microenvironment includes nerve fibers arising from the peripheral nervous system. The formation of new nerve fibers within and around solid tumors plays an active role in cancer development, progression and resistance to treatment. This proposal will explore the exact mechanisms that drive nerves to infiltrate tumors and support their growth and progression.